Histone H2A.X signaling and chromatin remodeling in late erythropoiesis

Erythropoiesis is a process of enormous magnitude, with the average adult producing approximately 2.5 million
red blood cells each second. To maintain this impressive output, terminal erythroid maturation is coupled with
rapid proliferation. In the span of 3-4 cell divisions, erythroid cells must condense their nuclei to approximately
1/10th of their original volume in anticipation of enucleation, which involves a dramatic compaction of the
erythroid genome. Disruption this process is associated with myelodysplastic syndromes (MDS) and
congenital anemias. The mechanisms involved, however, are poorly understood. Recent evidence from our
group and others has implicated the variant histone H2A.X as an important component in normal erythroid
maturation. Phosphorylation of this histone at S139 (γ-H2A.X) is an early feature of DNA repair pathways and
contributes to the stability of broadly-distributed “foci” of DNA repair factors. Notably, we observe a burst of γ-
H2A.X foci at a specific stage of erythroid maturation, concomitant with a significant increase in proliferation
and replication rate, and with the final stages of nuclear condensation. Based on this and other observations,
we hypothesize that histone H2A.X phosphorylation signals directly to downstream pathways that accomplish
chromatin remodeling (through histone exchange) and compaction (through the induction of an apoptotic-
related pathway). These studies will provide mechanistic insight into the still-opaque processes involved in
terminal erythroid maturation, enhance our understanding of epigenetic gene regulation and chromatin
compaction, and illuminate the basis for defects in erythropoiesis that can cause anemia.

Public health relevance
The goal of this proposal is to gain a fuller understanding of processes involved in the formation of mature, enucleated red blood cells. Many anemias are associated with defects in the normal packaging of genomic DNA that typically occurs in the progenitors of red blood cells. We will test the hypothesis that this packaging results from a signal generated on replicating DNA in the normal course of red cell development.